Acquisition of an electron cryo-microscope for structural biology

DESCRIPTION (provided by applicant): Cryo-electron microscopy has gained strong prominence as a technique suitable for structural analysis of macromolecular complexes and cellular architecture. Funding is sought to acquire a state-of-the-art transmission electron cryo- microscope to establish an electron cryo-microscopy facility, devoted to research and education in structural biology, at Mount Sinai School of Medicine. The proposed equipment includes 1) a JEM-1400 transmission electron microscope with capability to image cryo-specimens;2) cryo-transfer equipment to preserve biological specimens at liquid nitrogen temperatures and 3) a charge-coupled device (CCD) camera for data collection. This facility will be available to all Mount Sinai School of Medicine investigators, and will immediately impact vigorous NIH- funded ongoing electron microscopy efforts by several major users to study the structure of membrane proteins, protein/DNA complexes and macromolecular machines and to understand their role in biology and disease. PUBLIC HEALTH RELEVANCE: Our goal is to establish an electron cryo-microscopy facility at Mount Sinai School of Medicine to study the architecture of macromolecules and cells, and understand their role in biology and in disease.

Public health relevance
Our goal is to establish an electron cryo-microscopy facility at Mount Sinai School of Medicine to study the architecture of macromolecules and cells, and understand their role in biology and in disease.